Lineage Addiction in Prostate Cancer: Molecular Interactions and Translational Biomarkers

PROJECT SUMMARY/ABSTRACT – PROJECT 1
Metastatic prostate cancer (PC) remains the 2nd leading cause of cancer death in men in the United States.
However, with the development of novel therapies, a subset of patients experience an improved prognosis with
a median survival > 5 years. These recent advances combine Androgen Deprivation Therapy (ADT) with potent
Androgen Receptor (AR) Pathway Inhibitors (ARPIs) such as Abiraterone, Enzalutamide, Apalutamide, and
Darolutamide. However, none of these treatments are curative and it is now clear that multiple molecular
alterations culminate in Castrate Resistant Prostate Cancer (CRPC). This spectrum of CRPC encompasses
tumors that are androgen and AR dependent, androgen independent but AR dependent, tumors that permit AR
activation independent of traditional androgenic ligands, and tumors that are truly AR independent including
neuroendocrine prostate cancer1,2. Despite this, ~20% of men with CRPC who are treated with a second ARPI,
after progression on the first ARPI, can respond and derive clinical benefits to therapy for 1-2 years. This disease
heterogeneity identifies a critical need to identify the molecular drivers and associated biomarkers for patients
with AR driven CRPC for optimal sequence of therapy as well as novel interventions.
Using integrated genomic/transcriptomic sequencing data from metastatic biopsies of over 700 men, we have
identified that the majority of patients with mCRPC progressing on an ARPI exhibit a persistent luminal lineage
state that retains AR dependency. In this series, luminal adenocarcinomas with predominant lymph involvement
showed the greatest duration of benefit to ARPIs, as well as a subset of patients with bone metastatic PC. To
study these cellular interactions and molecular alterations that mediate durable luminal identity and sensitivity to
AR therapies, we have developed a novel “Tumor-on-a-Chip” technology called LumeNEXT. LumeNEXT
recreates endothelial microvessels in a fully humanized 3-dimensional cellular matrix composed of tumor,
stromal, and immune cells that can be identified in each metastatic niche. We have utilized LumeNEXT to identify
reactive fibroblast and osteoclast interactions with luminal prostate cancer cells to inhibit ARPI-induced cell
death. This contrasts to a primary PC environment which retains greater ARPI sensitivity and supports the
hypothesis that cellular interactions in distinct metastatic TMEs influence AR transcriptional activity mediated by
multi-omic interactions.
We will test this hypothesis using both LumeNEXT and PDX models of different types of ARPC with escalating
complexity of genomic mutations that cause resistance to ARPIs. We will study the largest tissue biopsy for these
molecular signatures and clinical correlations. Liquid biopsy validation will be performed in multiple prospective
studies will translate these findings into clinically actionable targets with novel agents currently in development.

Public health relevance
PROJECT NARRATIVE – PROJECT 1 Our understanding androgen receptor prostate cancer (ARPC) is the most common subtype of treatment resistant castrate resistant prostate cancer. We hypothesize that ARPC exhibits unique androgen receptor dependency that cooperates with specific tumor microenvironments in bone and lymph node to drive lethal prostate cancer. In this project, we will evaluate escalating complexity in genomic mutations that drive AR transcriptional programs in each of these niches and will be evaluated in prospective trials. These efforts will be greatly supported by the interactions with Project 2 and Project 3 and to understand why some prostate cancers undergo lineage transitions and others remain addicted to androgen receptor signaling.